Unraveling the functional contribution of extracellular vesicles in pancreatic cancer

PROJECT SUMMARY/ABSTRACT
Despite major advances in cancer treatment over the last 20 years, metastatic pancreatic
adenocarcinoma (PDAC) remains largely unresponsive to treatment. Signaling between cancer
cells and the surrounding host tissue microenvironment (TME) is a critical regulator of tumor
progression and metastasis, but an incomplete understanding of these interactions has hindered
therapeutic targeting. Recent studies have identified extracellular vesicles (EVs) as potential
mediators of intercellular communication to regulate cancer progression and metastasis. As a
result, targeting EV transfer and/or the downstream effects of such transfer may provide
therapeutic benefits; however, an understanding of the precise mechanisms of EV release and
entry into target cells, and the functional consequences of EV exchange in vivo is urgently needed.
Here, I will test the central hypothesis that cancer cell EVs modulate the tumor
microenvironment to facilitate PDAC progression and metastasis. I will use novel genetically
engineered mouse models to track and determine the functional impact of cancer cell EV (ccEV)
transfer on the local and metastatic TMEs to alter PDAC initiation, progression, and metastasis.
This will be accomplished through 3 Aims: (1) to investigate the functional contribution of ccEVs
in PDAC initiation and progression, (2) to evaluate the functional contribution of ccEV release and
CD47 on the surface of ccEVs in liver metastasis, and (3) to identify the role of mutant Trp53 and
novel EV mediators of stromal reprogramming to facilitate liver metastasis. The proposed
research program combined with additional research and career development skills training will
enable me to launch my independent research career. I will be committed to expanding my
networking, mentoring, leadership, lab management, and scientific communication skills, and I
have assembled an advisory committee consisting of Dr. Ronald DePinho, Dr. Anirban Maitra,
and Dr. Elizabeth Shpall to provide input and guidance on my career development. Altogether,
this K22 award will help me accomplish my long-term goal of understanding the mechanisms of
intercellular communication between cancer cells and the microenvironment to facilitate
pancreatic cancer initiation, progression, and metastasis in order to identify novel therapeutic
vulnerabilities.

Public health relevance
PROJECT NARRATIVE Extracellular vesicles (EVs) have emerged as potential mediators of communication between cells to alter cancer progression; however, the mechanisms regulating their release and uptake by cells and the functional consequences of such exchange are largely unknown. Here, I employ novel genetically engineered mouse models to elucidate how cancer cell-derived EVs modulate recipient cells to regulate pancreatic cancer progression and metastasis.